Air Particulate Pollution and Stress: Effects and Mechanisms for Long-term Maternal Obesity Risks

SUMMARY
In pregnancy, women typically gain 16-40 pounds and undergo numerous physiological changes with potentially
long-lasting consequences. Yet, research on pregnancy as a window of susceptibility to environmental
exposures has focused primarily on the child and largely overlooked women’s long-term weight gain and
cardiometabolic health. Emerging risk factors for obesity include air pollution that acts via respirable fine particles
<2.5 μm (PM2.5) and psychosocial stress. Our preliminary data identify pregnancy as a unique window of
vulnerability to PM2.5 and stress for women, indicating that effects of air pollution and stress during pregnancy
may be critical for women’s health over their lifecourse. Pregnancy requires the development of a new organ—
the placenta—which has long been recognized as a mediator of fetal programming. Increasing evidence
implicates micro (mi)RNAs as regulators of this process, but their role in long-term maternal programming has
not been considered. Supported by previous work and our preliminary data, we hypothesize that exposures
during pregnancy disrupt miRNA signals released by placental trophoblasts within nano-sized extracellular
vesicles (EVs) into the maternal circulation, programming maternal tissues toward obesity and cardiometabolic
conditions. To our knowledge, the joint effects of air pollution and stress on mothers during pregnancy have not
been studied, nor have EV-miRNAs been investigated as potential long-term, pregnancy-specific mechanisms
regulating maternal outcomes. We will address these gaps in the PROGRESS study, a high-risk population in
Mexico City with high but variable PM2.5 exposure and high psychosocial stress exposure. By studying
PROGRESS mothers recruited in pregnancy, we can cost-effectively conduct a longitudinal study from the 2nd
trimester through 10 years after pregnancy. We will also conduct state-of-the-art plasma metabolomic profiling
to enhance capacity of identifying early metabolic changes. In Aim 1, we will determine the impact of higher
PM2.5 exposure during pregnancy on weight retention 1 year post-partum, as well as on adiposity (weight, BMI,
waist/hip circumferences, body fat %), cardiometabolic biomarkers (blood glucose, insulin resistance, lipids,
adipokines) and ultrasound-based measures of subclinical carotid atherosclerosis longitudinally over 10 years.
In Aim 2, we will determine the impact of higher levels of stress from life experiences (violence, depression,
negative life events) and stress biomarkers (diurnal salivary cortisol rhythms) during pregnancy on those same
adiposity and cardiometabolic endpoints—independently and/or jointly with higher PM2.5 exposure during
pregnancy. In Aim 3, we will investigate the impact of PM2.5 and stress on placenta-specific EV-miRNA during
pregnancy and on the women’s metabolome 1 month and 4 years after delivery. In Aim 4, we will apply statistical
causal modeling to characterize the patterns linking EV-miRNA and metabolomics with PM2.5, stress, cortisol
rhythms, and maternal adiposity and cardiometabolic health. If successful, our work will impel interventions that
may help millions of women to prevent lifelong changes in body weight and adverse cardiometabolic outcomes.

Public health relevance
PUBLIC HEALTH STATEMENT The childbearing years are a critical life stage for weight gain and long-term cardio-metabolic health in women, but they are also a key time when interventions (indoor air filtering, stress reduction, or diet changes) can be implemented effectively. If successful, our work will motivate pregnancy-directed interventions that may help millions of women to prevent lifelong changes in body weight and related adverse health consequences.